Mechanisms of mitochondrial transcription

DESCRIPTION (provided by applicant): Genetic or age-related defects in mitochondrial gene expression can reduce or eliminate mitochondrial function and cause multiple human pathologies, including neurodegenerative and cardiovascular disease, diabetes and cancer. Mitochondrial transcription is a key process for gene expression, and accordingly some of these pathogenic alterations have been associated with proteins involved in transcription. However, our functional understanding of the different components of the transcription machinery in mitochondria is relatively poor. Characterizing the molecular mechanisms underlying mitochondrial transcription will allow us to understand how small genetic or environmental alterations in this process can result in gene expression deficiencies and the development of mitochondrial pathology. This proposal aims to provide functional insight into the process of mitochondrial transcription and investigate the importance of the rRNA methyltransferase activities present in transcription factors. We aim to unravel the mechanism of transcription initiation, the connections between transcription and ribosome biogenesis and the relationship between transcriptional defects and mitochondrial disease. The proposal has three aims: (i) to investigate the structural and functional differences between two transcription factors related to 16S rRNA methyltransferases, TFB1M and TFB2M, and to study the specificity of their interaction with their nucleic acid substrates; (ii) to investigate the methyltransferase activitie of TFB1M and TFB2M, their importance for transcription and ribosome biogenesis and their relationship with maternally inherited deafness; (iii) to determine the mechanisms of transcription initiation, the protein-protein interactions necessary for the process and the architecture of the transcription machinery. The proposal will take advantage of substantial preliminary data, including two novel crystal structures, the discovery of a novel interaction critical for initiation and the development of new methods to study the rRNA methyltransferase activities in vitro. We will apply various molecular genetics, biochemical and biophysical techniques to investigate the functional interactions necessary for transcription and the enzymatic activities of TFB1M and TFB2M. Electron microscopy, small angle x-ray scattering and X-ray crystallography will be used to provide additional structural insight and, in turn, facilitate our functional understanding of the process. The expected results will dramatically increase our knowledge of mitochondrial transcription, the individual roles of transcription factors, the relationships between transcription and ribosome biogenesis and the molecular basis of maternally inherited deafness. Ultimately, improving our mechanistic understanding of the transcription process will help clarify the relationship between transcription, mitochondrial dysfunction and disease. PUBLIC HEALTH RELEVANCE: Deficiencies in mitochondrial gene expression affect a large proportion of the population and can cause or contribute to disease development. This proposal will study the molecular mechanisms responsible for transcription, a central process in gene expression, and will improve our understanding of the mechanisms by which deficiencies in this process can lead to mitochondrial pathologies. The expected results will be relevant to our understanding of mitochondrial function, the development of mitochondrial diseases and the contribution of mitochondrial genetic alterations to the onset of age-related pathologies.

Public health relevance
Deficiencies in mitochondrial gene expression affect a large proportion of the population and can cause or contribute to disease development. This proposal will study the molecular mechanisms responsible for transcription, a central process in gene expression, and will improve our understanding of the mechanisms by which deficiencies in this process can lead to mitochondrial pathologies. The expected results will be relevant to our understanding of mitochondrial function, the development of mitochondrial diseases and the contribution of mitochondrial genetic alterations to the onset of age-related pathologies.